Microbiome Influences on Asthma-Related Outcomes in Early Life

BEAMS ABSTRACT: Project 1
Observations by our group and others indicate that risk for asthma originates very early in life. Some of the
implicated early childhood environmental exposures, such as to farms and pets, can inform establishment and
development of the gut microbiome in the neonate. This in turn may affect asthma risk through influencing both
the child’s immune development and response to respiratory infections such as those due to rhinovirus. Maternal
prenatal factors, including immunological phenotype and microbiota, similarly may influence development of the
child’s microbiota and asthma risk. We recently showed that Mexican-American schoolchildren living in Tucson,
AZ, have a fourfold higher rate of asthma than those living in nearby Nogales, Mexico (MX). We also showed
that infants born in Tucson and Nogales, MX, who are ancestrally related, are exposed to dramatically different
home environments and have differential gut microbiota characteristics at 1 month of age. We postulate that
exposure to specific microbial taxa in Nogales, MX may account for the relative protection against asthma as
compared to Tucson, and that this protection is mediated by differential seeding of the infant’s gut microbiota in
Tucson as compared to Nogales, MX. Project 1 of BEAMS will identify divergent early-life microbial and
immune developmental trajectories associated with asthma protection in Nogales, MX compared with
Tucson, AZ, and the microbiota exposures that promote them. Aim 1 will identify maternal factors related to
asthma protection, including characteristics of maternal (gut, vagina) and environmental (dust, water) sources of
differentially present microbiota, as well as immunologic characteristics which may relate to these exposures.
We will extensively phenotype these PBMCs using multiplexed cytokine panels and CyTOF, to identify cellular
phenotypes and characteristics that relate to exposures, location, and asthma outcomes in the child. Finally, we
will identify differential DNA methylation patterns from cord blood collected during delivery that relate to the
transborder differential microbiota and immune outcomes. Aim 2 will identify infant gut microbiota, environmental
and maternal factors, and infant immune cellular characteristics and phenotypes related to asthma protection, in
early life and longitudinally, using as an early asthma-related outcome the presence of wheezing with type 2
inflammation (T2 Wheezing, T2W) at age 2. Further, we will use single-cell analyses to identify differential
cellular transcription and development related to location and in response to ex-vivo stimulation with rhinovirus.
Aim 3 will identify the specific microbial exposures that may modulate the association between polymorphisms
in the asthma risk locus at chromosome 17q and wheezing lower respiratory illnesses at each location. This
innovative project utilizes a longitudinal, multiple-omics approach to identify potential microbiological and
immunological pathways by which exposure to dramatically different urban environments, prenatally through
early-life, may be associated with asthma protection or risk.